Administrative Core

The overall goal of the UT Houston Substance Abuse Research-Medication Development Center (SARMDC) is to develop safe and effective medications for cocaine dependence through the study of the behavioral and neurochemical mechanisms associated with the promising initial findings of replacement therapy. The Administrative Core will promote this goal by serving as a general resource for other projects and the Advanced Clinical Design & Statistical Methodology Core. The Specific Aims of the Administrative core are listed below: Aim 1. To provide infrastructure support for clinical trials issues, including: a) subject recruitment and screening b) urine toxicology testing, c) ensuring subject confidentiality and compliance with IRB and HIPPA requirements and regulations d) documenting clinical trials on clinicaltrials.gov. e) oversight of data sharing with NIDA. Aim 2. To provide support for Training and Education, including recruitment, supervision, and evaluation of trainees affiliated with the center. Aim 3. To provide Fiscal and Management support, including support for pilot studies, budgetary oversight, and management of research staff. Aim 4. To serve as the Liaison between the center and outside entities including the Department of Psychiatry, the UT Health Sciences Center, the Center for Clinical Translational Science of the University of Texas Health Science Center at Houston, the scientific advisory board, collaborating entities including addiction researchers at Baylor College of Medicine and University of Texas Medical Branch (UTMB) in Galveston, as well as NIDA.

Public health relevance
The administrative core of the UT Houston Substance Abuse Research-Medication Development Center (SAR-MDC) will promote the goal of the center, to gain a greater understanding of the basic neurobiology of cocaine dependence in order to develop safe and effective treatments of the disorder, by providing infrastructure for clinical trials, training and education, and fiscal managerial support for the projects of the center